Mechanisms of Action for mobile SMS PrEP adherence intervention

ABSTRACT
Effectiveness of pre-exposure prophylaxis (PrEP) for HIV prevention methods currently available to cisgender
women hinges on daily medication adherence, yet >50% of women discontinue within the first month of use.
Digital technologies to improve adherence to HIV treatment and prevention interventions are rapidly expanding
in the WHO African Region, despite mixed effectiveness findings. Systematic reviews note the near absence of
articulated mechanisms of action (MoA) for HIV digital health strategies which limits translation into practice and
thus population-level impact. Tools from behavioral health research and implementation science are useful to
elucidate, articulate, and test MoA for digital strategies. There is substantial pragmatic value in understanding
MoAs and moderators for how digital strategies work, including adapting intervention message content balance
to emphasize the most potent mechanisms and tailoring content to specific populations. We propose an R21 to
utilize data from the mWACh PrEP study (R01NR019220), a hybrid effectiveness-implementation trial that tests
the impact of a two-way, interactive, SMS-based platform on PrEP adherence and maintenance (continuing
PrEP refills and use) during pregnancy and postpartum in Kenya. The parent study includes 5 study sites based
at public sector antenatal clinics in a setting with high HIV prevalence. To date N=600 (100% of planned
enrollment) women are enrolled (1:1 randomization) to be followed until 9 months postpartum. The trial utilizes
the Information-Motivation-Behavior (IMB) model, which specifies 1) knowledge acquisition, 2) motivation, and
3) behavioral skills as potential MoA. Within this R21, we propose to test hypothesized MoA for the mWACh
PrEP digital strategy, assess specific context variables as moderators, and characterize experiences of MoA
activation. In Aim 1, we will test whether knowledge acquisition, motivation, and behavior skills are MoA through
which mWACh PrEP influences PrEP adherence and maintenance. We will consider both self-reported
adherence, hair concentrations of PrEP, and PrEP continuation. We will employ deductive analysis using
structural equation modeling and inductive analysis using coincidence analysis. In Aim 2, we will elucidate
whether MoA are moderated by mental health, relationship climate, sexual behavior, access to care, and medical
history, using structural equation modeling. Finally, in Aim 3, we will characterize how and why MoA are activated
by assessing the experiences of women, SMS content, and health provider insights. We will conduct in-depth
interviews with women, analyze two-way messages between women and providers, and engage facility and
study staff through a workshop to understand activation of MoA. Our study is designed to move the field from
theoretical to empirical knowledge of how and why women maintain and sustain PrEP use behaviors. Our
findings will have pragmatic utility beyond HIV prevention in pregnancy for adapting digital message content to
emphasize potent mechanisms and tailor message content to diverse populations.

Public health relevance
NARRATIVE Mobile health innovations to support adherence could fill an important gap in HIV prevention care delivery. Within this project, we propose to test how and why a specific mobile health intervention works to improve adherence to pre-exposure prophylaxis by examining pregnant and postpartum women’s experiences, their mobile message content, and their responses to study questions about information, motivation, and gaining behavioral skills.